NRSA Training Grant in Quantitative Neuroscience

This proposal is for the renewal of a predoctoral and postdoctoral Quantitative Neuroscience Training Program
(QNTP) at Princeton University. Neuroscience research is becoming increasingly quantitative. Formal theoretical
techniques are essential for understanding how complex, large-scale interactions between neurons give rise to
thought and behavior, and advanced quantitative methods of data analysis are necessary for addressing the
increasingly large, multidimensional data sets generated by modern brain imaging techniques (e.g., multiunit
recording, fMRI). These methods are also necessary for future progress to be made in understanding,
diagnosing, treating and, ultimately, curing brain disturbances that give rise to psychiatric disorders.
Unfortunately, the mathematical and computational skills required to address these needs are not a focus of
standard neuroscience curricula. Princeton’s QNTP is designed to address this need, by providing the next
generation of neuroscientists with the necessary mathematical and computational skills for measuring, analyzing,
and modeling brain function. The establishment of the QNTP sparked several developments at Princeton, that
(in turn) have accelerated the pace at which the goals of the QNTP are being met. By bringing Princeton’s
neuroscientists together with faculty in Physics, Mathematics, Computer Science and Engineering, the QNTP
helped to spur the formation of the Princeton Neuroscience Institute (PNI) in 2005. The QNTP also helped to
inspire the formation (in 2008) of PNI’s free-standing PhD Program in Neuroscience, which strongly emphasizes
classroom and laboratory training in basic quantitative and computational methods during its first two years.
These developments have made it possible for us to refocus the QNTP from its original purpose (providing a
foundation in quantitative neuroscience for trainees who are starting out in this area) to providing advanced
training in quantitative neuroscience. Specifically, we will take the most quantitatively-focused subset of our
predoctoral and postdoctoral trainees and provide them with the additional tools and training that they need to
excel in computational neuroscience research. This training will be accomplished via advanced quantitative and
computational neuroscience elective courses that were developed for the QNTP and are taught by leaders in
the field, as well as participation in research seminars, journal clubs, and career development activities that are
designed to deepen the trainees’ knowledge and bolster community among the trainees. PNI faculty have made
seminal contributions to quantitative neuroscience, ranging from information-theoretic analyses of neuronal
spiking and dynamical systems analysis of decision-making to multivariate decoding of human neuroimaging
data. The QNTP has been specifically formulated to bring predoctoral and postdoctoral trainees into contact with
this expertise and, through this, to catalyze their transformation into full-fledged computational neuroscientists.
Given the sustained increase in the number of faculty and our graduate student cohorts, we are requesting
support for six predoctoral trainees and six postdoctoral trainees (with 2 year appointments for each trainee).

Public health relevance
This is an application for support for advanced predoctoral and postdoctoral training in quantitative neuroscience. By instructing our trainees in computational modeling and advanced data analysis techniques, we aim to train scientists that will be able to bridge the key gap in our understanding of how the brain works: how do myriad single molecules and neurons collectively give rise to the mind? This is important for both basic science and clinical science - these modeling and data analysis techniques will give trainees a rich vocabulary and a powerful toolkit for exploring how pathologies of small-scale elements (e.g., deficits in neurotransmission at dopaminergic terminals) can lead to mental disorders (e.g., schizophrenia).